Frontal midline delta/theta rhythms and cognitive control in PD

Abstract
Cognitive symptoms of Parkinson’s disease (PD) include deficits in attention, working memory, and
reasoning. These deficits affect up to 80% of PD patients and lead to mild cognitive impairment (PD-MCI)
and dementia in PD (PDD). There is a critical need to better understand cognitive impairment in PD to
develop new targeted treatments. Our long-term goal is to define the mechanisms of PD-related cognitive
impairment. PD involves diverse processes such as dopamine and acetylcholine dysfunction, synuclein
aggregation, and genetic factors. During the past funding period, we linked PD-related cognitive
impairment to dysfunction in frontal midline delta (1–4 Hz) and theta (5–7 Hz) rhythms, which our work has
established as a marker of cognitive control. However, it is unknown why PD patients have deficits in these
low-frequency brain rhythms. Our preliminary magnetic resonance imaging (MEG) and
magnetoencephalography (MRI) implicate the anterior midcingulate cortex (aMCC) as a potential source
of frontal midline delta/theta rhythms. In the next funding period, our objective is to determine the
mechanisms and predictive power of delta/theta rhythms in PD, which will help to better understand the
pathophysiology of PD-related cognitive impairment. Collaboration between the University of New Mexico
(UNM) and University of Iowa (UI) that will bring together MEG, MRI, longitudinal EEG, and adaptive
subthalamic (STN) deep-brain stimulation (DBS). We will test the overall hypothesis that frontal midline
delta/theta dysfunction contributes to cognitive impairments in PD. In Aim 1, we will determine the structural
basis for delta/theta rhythm deficits in PD. In Aim 2, we will determine the predictive power of delta/theta
rhythm deficits in PD. In Aim 3, we will determine how tuned low-frequency STN DBS impacts cortical
activity and cognition. Our results will have relevance for basic-science knowledge of the fundamental
pathophysiology of cognitive impairment in PD and related dementias. Because this proposal will study
patients with PDD, our findings are directly relevant to Alzheimer’s-related dementias (ADRD).

Public health relevance
Project Narrative Cognitive symptoms of Parkinson’s disease are an enormous public health problem. We will analyze brain rhythms that are involved in cognitive processing and also dysfunctional in Parkinson’s disease, including in Parkinson’s disease dementia. We will use these brain rhythms to guide novel diagnostic tools and brain stimulation that has the potential to address dementia and cognitive impairments in Parkinson’s disease.